Mechanism of flagellar type-III secretion

Many species of bacteria swim using flagella, which consist of thin helical filaments turned by rotary motors in the cell membrane. Assembly of the bacterial flagellum depends on a specialized secretion apparatus at the base that exports the protein subunits needed to form exterior structures. The flagellar secretion apparatus obtains energy from the membrane ion gradient, and transports protein subunits more rapidly than other known export systems. At the center of the apparatus is a complex formed by the membrane proteins FliP, FIiQ, FIiR, FlhA, and FlhB. The mechanism of flagellar secretion is poorly understood, mainly due to the lack of information on this membrane-protein complex. The proposed work will use a variety of genetic and biochemical approaches to determine which proteins are essential for export, to elucidate their membrane topologies, and to identify functionally important domains and residues.

Public health relevance
Relevance The flagellar secretion apparatus is closely related, structurally and evolutionarily, to the "injectisome" system employed by many bacterial pathogens to to inject effector molecules into host cells, subverting cellular defenses and contributing to disease. Information on the flagellar system will be directly relevant to understanding the molecular mechanism of this secretion system used by pathogens, and may therefore contribute to strategies for combating infection.